Leveraging artificial intelligence to develop novel tools for studying infant brain development

PROJECT SUMMARY. The first 24-months of human life are dynamic, characterized by rapid growth, and
increasingly recognized as crucial for establishing cognitive abilities and behaviors that last a lifetime. However,
little is known about trajectories of structural and functional brain development during this sensitive period in
typically developing infants, and even less is known about how deviations in these trajectories relate to emerging
cognition and behavior or predict later developmental outcomes. This is partially due to current technical
limitations on quantification of brain structure and function in infants via magnetic resonance imaging (MRI) – an
important, non-invasive approach to the study of developmental neuroscience. Currently there are insufficient
methods to analyze infant MRI scans across the first 24 months of life, especially for brain segmentation – the
first and critical step for virtually all quantitative analyses across MRI modalities. Without accurate and automated
segmentation, infant MRI analysis is prone to systematic errors and is labor-intensive, limiting the rigor and
reproducibility of infant MRI research. This limitation curtails and delays the utility of large-scale infant MRI
datasets in the foreseeable future. Addressing these research gaps would significantly advance efforts toward
early identification of developmental delays and/or disorders. This proposal aims to capitalize developed artificial
intelligence methods and platform in the K99 phase by utilizing extensive infant MRI datasets from both the Baby
Connectome Project (BCP) and the Developing Human Connectome Project (dHCP), to delineate growth
trajectories of brain structure/function and measure the relationship between those trajectories and
neuropsychological functions (Aim 1), and then to predict the developmental outcomes (Aim 2). In Aim 1, I will
delineate the growth trajectories of regional brain morphometrics, major functional networks, and measure their
relationships to neuropsychological functions during the first 24months of life via data from BCP. In Aim 2, I will
leverage two different approaches (AI and LPCA) to predict the developmental outcomes assessed up to 3 years
old with the first-year longitudinal multimodal MRI scans from BCP. We will also validate our AI model with
multimodal MRI scans from dHCP, an independent dataset. The successful execution of this project is expected
to employ innovative data-driven methods to investigate the nuances of early brain development, filling critical
knowledge gaps of early development, and advancing efforts toward early identification of developmental delays.

Public health relevance
PROJECT NARRATIVE Little is known about the growth trajectories of brain development across the first 24-months of life because of insufficient approaches to analyze infant MRI scans especially brain segmentation. This proposal leverages artificial intelligence and large-scale datasets to address unmet technical challenges in infant brain segmentation, to delineate the growth trajectories of brain structure/function and measure their relationship with neuropsychological functions, and to predict the developmental outcomes. Results from this study will address fundamental methodological limitations and fill critical knowledge gaps of early development, advancing efforts toward early identification of developmental delays and disorders.